Genetic and Biochemical Mechanisms of Regulation

DESCRIPTION (provided by applicant): This project supports the training of nine students annually at Brandeis University in the field of genetics, who will be appointed in the second year of their Ph. D. training. This grant has played a central role in the education of a highly productive group of interactive graduate students actively involved in genetics research in problems relating to molecular, cell, and developmental biology and neuroscience, with relevance to the mechanisms and treatment of human disease. The Training Grant Faculty are drawn from highly collaborative and interdisciplinary researchers in the Departments of Biology and Biochemistry. Students work in well-funded and productive laboratories that are supported by recently upgraded core facilities in DNA and protein analysis, proteomics, genomics, microscopy and mouse and viral transgenics. The proposed program emphasizes rigorous training to develop research and other professional skills including scientific literacy, writing and oral communication and quantitative approaches. The Ph. D. program has a core curriculum of molecular biology, cell biology and ethics and advanced genetics courses, which includes molecular genetics, neurogenetics, population genetics and genomics, epigenetics and human genetics. These core courses are supplemented by elective courses in biochemistry, structural biology, developmental biology, mathematical modeling or neuroscience and courses concerning human diseases such as cancer, infectious disease, neurological and development disorders. Trainees are appointed based on the strength of their academic records and research potential and are supported for two to three years. Progress of the students is closed monitored by a committee of Training Grant Faculty selected for each student. Qualifying examinations at the end of the first and second years provide a means to evaluate each student's ability to frame questions and propose research solutions in their emerging area of expertise and in an outside field. The training of students is supplemented by seminars and journal clubs, featuring a wide variety of successful investigators in diverse areas of biological research. A number of professional development activities feature valuable personal discussions that assist each student's career planning. Special opportunities for Trainees include enhanced personal interactions with speakers and participation in an annual Genetics Symposium. In addition, Trainees work with Training faculty in the planning and implementation of these activities. The program is assessed yearly through online surveys and personal discussions with Trainees. This, and the small size and interconnectedness of students and faculty, provides training responsive to the needs of each student in a first-class research setting.

Public health relevance
This project trains nine Ph. D. students yearly in the field of genetics at Brandeis University. Along with intensive coursework and research training, students work on basic mechanisms of disease and its treatment, including neurodegeneration, developmental disorders, heart disease, cancer and infectious disease. This training features the development of skills necessary for students to become productive and independent contributors in the fields of scientific and medical research.